TimsTOF-fleX MALDI-2 mass-spectrometer

PROJECT SUMMARY
The Advanced Science Research Center (ASRC) of the City University of New York (CUNY) is requesting
funds from NIH through the High-End Instrumentation program to purchase a timsTOF-FleX MALDI-2, high-
resolution mass-spectrometer with trapped-ion mobility (TIMS) technology and a dual ion-source platform for
metabolomics and proteomics studies. This instrument will support biomedical research projects of twelve
laboratories from within CUNY and nearby institutions, including investigators from the Structural Biology and
Neuroscience Initiatives at the ASRC, City College of New York, neighboring institutions in New York
(Columbia University, Rockefeller University), and other laboratories in the region and nationally. The projects
span biochemistry and structural biology from macromolecular to metabolomic levels, with two general areas of
focus: (1) conformational dynamics of light-sensitive proteins, kinases, large systems as platelet integrins, and
ryanodine receptors; (2) metabolic signals regulating tumor progression, and axonal regeneration and to
metabolic control of brain cell population dynamics, with an emphasis on epigenetic regulation of glial cell
differentiation and dietary effects on metabolites affecting neurodegeneration. The anticipated outcomes are
better mechanistic definitions of processes regulating critical biological functions, giving insights into
fundamental biology, ways that these mechanisms are impacted by disease, and routes to successful
therapeutic and biotechnology strategies.
Currently, no similar instruments are available in shared facilities in the New York City area. The novel
technology incorporated into the proposed timsTOF-FleX MALDI-2 instrument will provide us with tools to
significantly enhance the sensitivity and resolution of our mass measurements, enabling separation of
challenging isomeric and isobaric species, confident detection and identification of many more molecular
compounds in various Omics studies, and use of Hydrogen-Deuterium Exchange mass-spectrometry to
increasingly complex macromolecular assemblies. Finally, the dual MALDI-MS and ESI-MS platform of
timsTOF-fleX MALDI-2 will provide our users with the ability to map molecular distributions in tissue in situ,
identify regions of interest that express the desired molecular profile, and selectively target these
subpopulations for integrated Omics analyses. Thus, should this proposal be approved by NIH, the novel
instrument will advance a number of collaborative research efforts in biomedical research being conducted at
the ASRC and beyond, expand training opportunities for early career scientists.
The instrument will be housed in the ASRC building and managed by the PI within the ASRC Mass-
Spectrometry Core Shared Facility. All projects that require integrated MALDI-Imaging and complementary
traditional Omics analysis will be supported by the MALDI-MS Imaging Joint Facility, co-directed by the PI and
Dr. Ye He, director of the ASRC Live Imaging and Bioenergetics Facility.

Public health relevance
PROJECT NARRATIVE This instrument will support biomedical research projects of twelve laboratories from within CUNY and nearby institutions, including investigators from the Structural Biology and Neuroscience Initiatives at the ASRC, neighboring institutions in New York, and other laboratories located throughout the region and nation. The anticipated outcomes are improved instrumental sensitivity, resolution, and other technical capabilities that will enable a diverse range of currently inaccessible experiments into fundamental mechanisms of biological control, critical for understanding life and disease at the molecular and level with implications for therapeutic and biotechnology applications.